Development of a Urine Genetic Test for NonMuscle Invasive Bladder Cancer

Development of a Urine Genetic Test for Non-Muscle-Invasive Bladder Cancer
There is an urgent unmet need for a test capable of comprehensive genetic characterization of
non-muscle-invasive bladder cancer (NMIBC) to guide treatment and for recurrence surveillance.
Bladder cancer (BC) is the 6th most common cancer in the US. Approximately 90% of BC cases
are urothelial carcinoma and 75% are NMIBC at diagnosis. The treatments and prognoses are
very different between NMIBC and muscle-invasive bladder cancer (MIBC). With limited
distinguishing molecular features, NMIBC and MIBC are classified based on the morphology and
depth of invasion, which is insufficient for reliable outcome prediction or treatment guidance.
NMIBC is a heterogeneous subclassification (stages 0 and 1) of urothelial carcinoma and is
characterized by high rates of recurrence and disease progression (as high as 40% within 2 years
of initial treatment, with roughly 10% of all cases progressing to MIBC). Cancer is a disease of
the genome; thus, BC genetic features should be the most definitive for its diagnosis, staging
subclassification, and treatment guidance. Urine has been shown to contain both BC tumor cells
and cell-free DNA (cfDNA). However, the complexity of the urine matrix and the low concentration
of urinary cfDNA have so far precluded the application of urine BC cfDNA analysis for diagnosis
and stratification. JBS Science Inc. has developed a novel, robust urine cfDNA isolation method
that overcomes these limitations. We thus hypothesize that this cfDNA isolation method will
enable the development of a urine genetic liquid biopsy for NMIBC. Such a test will provide
comprehensive NMIBC genetic profiling to distinguish NMIBC from MIBC, guide disease
management, and monitor recurrence. Two aims are proposed in this phase I feasibility study.
Aim 1 is to develop a BC-targeted, hybridization-based NGS assay and data analysis pipeline.
Aim 2 is to compare the tissue/urine and tissue/plasma variant concordances. In addition, a
preliminary analysis will be performed of the feasibility of the NGS test being capable of
distinguishing NMIBC from MIBC. The success of this phase I study will demonstrate the feasibility
of developing a urine test for comprehensive NMIBC genetic characterization that can be used
for BC diagnosis, recurrence monitoring, and distinguishing NMIBC from MIBC.

Public health relevance
Bladder cancer (BC) is the 6th most common cancer in the US. Approximately 90% of BC cases are urothelial carcinoma and 75% are NMIBC at diagnosis. The treatments and prognoses are very different between NMIBC and MIBC. With limited distinguishing molecular features, NMIBC and MIBC are classified based on the morphology and depth of invasion. This project is to develop a noninvasive urine test to provide a comprehensive genetic characterization of non- muscle-invasive bladder cancer (NMIBC) to guide treatment and for recurrence surveillance.